Opposing Functions of BRD4 Isoforms in Breast Cancer

Abstract
Genetic mutation and non-mutational epigenetic control of gene expression that alter transcription
programs in normal and perturbed cells often lead to pathological phenotypes requiring medical attention.
Identifying the gene targets and pathways underlying these abnormalities, particularly in cancer cells, is crucial
for developing appropriate regimens for disease treatment. Nevertheless, the heterogeneity of cancer cells
makes it difficult to develop a universal treatment plan that works for every patient.
Over the past 10 years, bromodomain-containing protein 4 (BRD4) has emerged as a promising cancer
therapeutic target due to its broad association with active enhancers that modulate transcription programs
implicated in cancer initiation and progression, and importantly, the availability of small compound inhibitors
targeting BRD4 and its related family members that also include BRD2, BRD3, and BRDT in humans. These
bromodomain and extra-terminal (BET) family protein inhibitors, such as JQ1 and I-BET, show great promise in
reversing cancer phenotypes in cultured cells and animal models. Several of these compound derivatives are
now in clinical trials for treating various types of cancer and inflammatory disease, and their therapeutic targets
have been attributed mainly to the BRD4 long isoform (BRD4-L, aa 1-1362). Recently we found, by isoform-
specific knockdown and endogenous protein detection along with transgene expression, that the less abundant
BRD4 short isoform (BRD4-S, aa 1-722) is in fact oncogenic while BRD4-L is tumor-suppressive in breast
cancer cell proliferation and migration as well as in mammary tumor formation and metastasis. Our central
hypothesis is that BRD4 isoforms have opposing functions, although they do share some common properties,
in tumor development, which will be stringently tested by addressing the following three specific aims:
1. To define the biological role of BRD4-L and BRD4-S in different breast cancer cells and mouse models
2. To elucidate the mechanistic action of BRD4 isoforms and their coregulators in breast cancer subtypes
3. To identify gene targets and pathways uniquely and commonly regulated by BRD4 isoforms
Since isoform-specific BRD4 antibodies and a new class of phospho-BRD4-targeting compounds with
molecular action distinct from the BET bromodomain inhibitors have now been successfully developed in my
lab, we are in a unique position to address pressing issues implicated in BRD4-targeted cancer therapy. Our
immediate goals are to identify cellular pathways uniquely and commonly regulated by each BRD4 isoform
using biochemical and molecular tools, synthetic chemistry, and genome-wide expression and binding profiling
to elucidate BRD4-L and BRD4-S involvement in breast cancer. Our eventual goals are to provide validated
molecular pathways and new gene targets for effective breast cancer treatment in the near future.

Public health relevance
Project Narrative (Public Health Relevance Statement) Bromodomain-containing protein 4 (BRD4) is an emerging cancer therapeutic target whose functional inhibition by two widely used small compounds (JQ1 and I-BET) often leads to suppression of cancer-associated phenotypes; nevertheless, insensitivity to drug treatment and development of drug resistance upon prolonged treatment remain serious concerns in cancer therapy. In our preliminary studies, we found that BRD4 has two predominant protein isoforms with the long (L) form likely being tumor-suppressive and the short (S) form potentially being oncogenic. In this proposal, we will investigate the functional role of BRD4-L and BRD4-S in regulating breast cancer cell growth and tumor progression and in gene programming using biochemical and molecular biological approaches, synthetic chemistry, genomics, proteomics, and mouse breast cancer tumor models with concurrent analysis of human breast cancer specimens, which collectively will unravel the mechanisms by which BRD4 regulates normal and cancer cell growth and tumor progression as well as provide a rationale for BRD4-targeted cancer therapy.